Health Equity Academic Research in Pediatric Hospital Medicine (HEAR-PHM) Program

Project Summary/Abstract
The Health Equity Academic Research in Pediatric Hospital Medicine (HEAR-PHM) Program will build capacity
to address disparities across the acute care continuum by both delivering a health equity research curriculum
to pediatric hospitalists and supporting a diverse academic workforce within Pediatric Hospital Medicine
(PHM). Disparities have been identified across the spectrum of care and conditions for the hospitalized child.
Although responses to address disparities in pediatric care need to be multi-factorial, key strategies include
developing expertise in health equity research and fostering a more diverse academic workforce. A dedicated
focus on increasing diversity in the pediatric workforce has been identified as a national priority. Cultural make-
up of the United States is changing, and data from the US Census Bureau projects by 2060 only one-third of
US children will be non-Hispanic white. Developing and maintaining a diverse academic pediatric workforce is
an important aspect to improve health outcomes in populations underrepresented in medicine (URiM). PHM is
a young subspeciality that has opportunities to address health inequities for hospitalized children and needs
specialized health equity research training. To address this critical gap, HEAR-PHM seeks to: 1) Prepare PHM
scholars (fellows and junior faculty) to lead health equity research in the care of hospitalized children. The
scholars will be equipped with a background in health equity research skills, and support completion of an
impactful, rigorous capstone research project focus on child health equity; 2) Enhance the diversity of PHM
scholars. We will recruit URiM scholars from a national applicant pool, with attention to diversity in clinical and
academic backgrounds, socioeconomic status, race/ethnicity, and sex/gender preference; 3) Build a repository
of health-equity research resources to support the train-the-trainer model for PHM scholars. We will develop an
online platform to support the health-equity research lectures, develop a toolkit for scholars to train others, and
provide opportunities for scholars to share their experiences and knowledge locally and nationally. Children’s
National Hospital (CNH) is well-position to lead this national program as it is one of the oldest and largest PHM
programs in the country, and CNH has long-standing expertise in medical education, translational research,
and community-based programs. HEAR-PHM program directors are national PHM leaders with strong
reputation as educators and researchers, and program scholars will leave the program with enhanced health
equity research capabilities related to the mission of NICHD.

Public health relevance
Project Narrative The proposed research is relevant to public health because health disparities have been identified across the spectrum of care and conditions for the hospitalized child; although responses to address disparities in pediatric care need to be multi-factorial, key strategies include fostering a more diverse pediatric workforce and developing expertise in health equity research. The project is relevant to NICHD’S R25 mission because Health Equity Academic Research in Pediatric Hospital Medicine (HEAR-PHM) is a research education program that supports creative education activities to focus on research skill development in an area of critical need, specifically health equity research focused on the acute care continuum for children. As a young pediatric subspeciality with care expertise across a broad spectrum of hospital care, PHM has the unique opportunity to promote a diverse academic workforce and develop research leaders to improve health equity in the care of hospitalized children.